Predictive Modeling of Multidimensional Anti-Influenza IgG Repertoires

Project Summary Annual immunization against inﬂuenza infection is one of the largest coordinated international public health ef- forts. Current inﬂuenza vaccination strategies elicit protection primarily through the generation of long lasting, type-speciﬁc, neutralizing anti-HA IgG antibodies. A major reason for the success of the seasonal inﬂuenza vac- cination is that it induces antibodies that bind to molecularly similar inﬂuenza subtypes. However, we currently lack both high throughput assays and multidimensional analytic methods to rapidly characterize comprehensive individual and population level IgG mediated immunity to a broad range of inﬂuenza strains, or to predict popula- tion immunity against new strains. The primary goal of this proposal is to develop an innovative multidimensional assay and quantitative modeling framework to characterize population level immunity to a large number of in- ﬂuenza strains, and predict responses to new inﬂuenza vaccines. In Aim 1, we will use a novel multiplex assay to measure pre-and post- vaccine anti-HA IgG reactivity against 50 inﬂuenza strains in 150 subjects. We then will test and validate a predictive model for vaccine induced changes in anti-HA IgG levels. In Aim 2 we will use the data from Aim 1 to estimate changes in population immunity pre- and post-standard seasonal inﬂuenza vacci- nation. Multidimensional scaling will be used to develop functional immune repertoire cartography, quantitatively modeling both the similarity of subject immune states and a model of vaccine-induced changes in the anti-HA IgG repertoire vector. Successful completion of these Aims will establish a new hybrid experimental-modeling method for predicting inﬂuenza vaccine responses and estimating population resistance to emerging inﬂuenza strains.

Public health relevance
Narrative Immunization against inﬂuenza results in protective antibodies that bind to the viral surface and prevent infec- tion, including cross-reactive antibodies that bind to other inﬂuenza strains. We have developed a method for measuring antibody levels against 50 inﬂuenza strains with a tiny blood drop from a ﬁnger stick. The goal of this proposal is to use this method, with mathematical modeling to predict inﬂuenza vaccine responses in individuals and populations. If successful, this work will create a new paradigm for evaluating inﬂuenza vaccine success in individuals and populations.